Modeling and Removing Visual Impairments for Endoscopic Kidney Stone Surgery

Modeling and Removing Visual Impairments for Endoscopic Kidney Stone Surgery
PROJECT SUMMARY/ABSTRACT
The importance of achieving stone-free status during endoscopic kidney stone surgery is emphasized by the
high rate of repeat stone procedures due to residual fragments after index surgery. Residual stone fragments
are caused by incomplete stone treatment and can lead to obstruction, pain, kidney injury, and recurrent
infections. Among other issues, blood and debris can frequently obscure the already limited field of view during
endoscopic stone surgery, impairing the surgeon’s ability to visualize kidney stones. Importantly, endoscopic
video is the primary means of locating and tracking stones during treatment. Though technical constraints
of scopes may also impact surgical kidney stone outcomes, the above limitations of endoscopic stone treatment
prevent many surgeons from achieving a complete stone-free status.
My goal is to test whether computer vision models can be used to quantify and remove visual impairments during
kidney stone surgery. I propose two Specific Aims to achieve these two objectives: Aim 1 will develop an
automatic, real-time method for quantifying visual impairments and seek to associate impairments with
surgical outcomes. Aim 2 will develop models for the virtual removal of visual impairments during surgery.
These studies will produce a novel method for the objective quantification of visual impairments during surgery
and means for the real-time digital removal of visual impairments from endoscopic stone surgery video. Success
in visual impairment removal could decrease the frequency of residual fragments and reduce the risk of
repeat stone surgeries. It could also lead to more efficient stone treatment, reducing operative time and
decreasing the risk of injury to the collecting system. As these models would require only software integration to
deploy in real-time on current endoscopic surgical cameras, all existing endoscopic surgical systems could in
principle immediately benefit from the results of this project.

Public health relevance
PROJECT NARRATIVE Each year, over 100,000 patients require an endoscopic (i.e. minimally invasive) surgery for kidney stone disease in the United States and approximately 25% require a repeat surgery. Visual impairments from debris and fluid during operation can result in increased difficulty tracking kidney stones during the operation. This study aims to create computer vision and machine learning models which quantify and remove the visual impairments encountered to improve endoscopic treatment of kidney stones.